Treatment of secondary injury after ischemic stroke through targeting microglia

DESCRIPTION (provided by applicant): Though the activated microglia/macrophages (Mɸ) are known to contribute to secondary brain injury after stroke, Mɸ are also instrumental in the repair process. To explain such contrasting roles, two Mɸ phenotypes, harmful/M1 and healing/M2, have been proposed. Importantly, the M1 Mɸ can be polarized to M2 and vice versa. While various molecules derived from stroke-injured cells have the propensity to polarize Mɸ toward M1 type (causing the generation of pro-inflammatory cytokines and pro-oxidants), other molecules (e.g. generated by T cells), such as IL-4, IL10 or TGFß, polarize Mɸ toward the M2 type. The M2 Mɸ control the cleanup processes (phagocytosis- mediated removal of toxic and pro-inflammatory cellular debris), and the production of trophic factors. Thus, the source of toxicity and the biological and physical barriers hampering neural reorganization are removed, while providing trophic support governing neuronal sprouting (the repair process). Without the M2 Mɸ, healing would not be possible. While both M1 and M2 Mɸ phenotypes co-exist shortly after stroke, M2 phenotype weakens within 2-3 days allowing M1 type to dominate. This adversely affects the brain cleanup, repair, and recovery, while boosting cytotoxicity. Exploring the mechanisms underlying such processes and therapeutic approaches aiming at rectifying the M2 polarization loss are the subjects of this proposal. Our novel findings indicate that in response to ischemia, neurons synthesize and release IL-4 (canonical M2 polarizing cytokine) during the first 3 days of stroke, followed by a decline in both IL-4 and M2 Mɸ levels. IL-4-induced M2 Mɸ polarization requires the activation of RXR-PPARγ pathway. The administration of IL-4 or agonists of PPARγ and RXR (rectifying factors) for 5 days, starting at 1d post stroke, improves recovery and neuronal re-wiring. Loss of PPARγ in Mɸ impedes recovery. Aim 1. Elucidate, in vitro, the role of neurons in Mɸ polarization and post stroke repair: IL-4- medaited PPARγ:RXR-executed process involving phagocytosis (cleanup) and trophic stimulation. Hypothesis: Neurons act as sensors of injury and generate IL-4/IL13 that signals to microglia to induce M2 polarization, while suppressing M1 phenotype associated with cytotoxicity. Aim 2. Elucidate, in vivo, the basis of IL-4 signaling to PPARγ:RXR, and apply them into clinically relevant approaches targeting the phagocyte-mediated brain cleanup, remodeling, and post- stroke recovery. Hypothesis: Because the initial polarization toward the healing Mɸ phenotype after stroke, driven by neuronal production of IL4/IL13, is lost within few days after stroke, approaches aiming at restoring IL-4-medaited signaling, such as via recombinant IL-4 and PPARγ:RXR activation (molecular targets of IL-4 in Mɸ), to rectify M2 polarization loss will assist in post stroke recovery.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stroke is the number one cause of adult disability in the United States with tissue plasminogen activator being the one approved therapy for acute ischemic stroke - but only 5% of patients receive it nationally, given the narrow therapeutic window. Growing body of evidence suggests that improvement of post/semi-acute stroke recovery may represent the next target for an effective treatment. We propose (and study in this application) that the optimization of cytotoxic, cleanup and repair properties of microglia/macrophages (Mɸ cells normally involved in scavenging and microbicidal activities) after stroke is an important and clinically relevant target that could provide benefits when delivered to stroke patients at the sub-acute stages.